In vitro bioreactor sys for platelet formation

DESCRIPTION (provided by applicant): Millions of platelet transfusions are conducted each year, yet the supply of this blood component is limited, thus patient access to treat disorders is problematic. There are also many diseases where platelet production or function are impaired, resulting in severe consequences and where there are limited clinical options available. To address these current limitations, new modes to generate functional platelets in vitro would provide a major benefit to many patients, as well as provide an approach to permit the systematic investigation of mechanisms involved in functional platelet formation. Our goal in this Project is to build upon our recent successful studies where a novel bioreactor system was engineered to house megakaryocytes (Mks) and to generate functional platelets in vitro. We will exploit this system to address our hypothesis; engineered microenvironments in vitro can be tailored to optimize the formation of functional platelets. To address the needs in the program we will: (Aim 1) establish a bioreactor-based 3D tissue system to study the mechanisms of Mk development and platelet release, with functional outcomes in terms of functional platelets generated and recovered from the system, and (Aim 2) to use this 3D tissue system to investigate mechanisms of platelet production related to biochemical signalling and environmental components (i.e. matrices, oxygen tension) as well as pathological megakaryopoiesis by including Mks from patients with platelet related diseases. With insight from this system we will be positioned to interrogate the maturation of Mks from both normal vs. diseased sources in order to begin to establish differences in Mk outcomes (adhesion, migration, proplatelet formation, platelet production and function). The outcome for the proposed study would be twofold: (1) a new laboratory model for Mk development, proplatelet formation and platelet release in normal and abnormal (disease) states, and (2) mechanistic insight into these processes. In the long run, building upon this new in vitro tissue system would allow for the more systematic understanding of the processes involved in Mk development, as well as insight into modes to intervene in disease states associated with these cells.

Public health relevance
PROJECT NARRATIVE Circulating platelets are highly specialized cells produced by Mks that participate in haemostatic and inflammatory functions. Millions of platelet transfusions are conducted each year but the supply of this blood component is limited. Despite their critical role in many physiological functions, little is known about the molecular mechanisms involved in platelet production from Mks, or about the pathogenesis of platelet disorders. With such widespread impact of these diseases, and the lack of good options for clinical treatments, new insight into the formation of platelets from Mks would have a major impact on patients and healthcare. To address this need, we plan to develop a novel human bone marrow system in vitro that can be used to understand the process of Mk formation and development both in normal and disease scenarios, as well as an innovative procedure to produce fully functional platelets for clinical needs. __SpecificAimsTextDelimiter__ SPECIFIC AIMS We propose to establish an in vitro tissue model and bioreactor system of hemopoiesis and megakaryopoiesis. The approach will be to reproduce bone and vascular niche environments to foster functional platelet formation and to study mechanisms of Mk development in both physiologic and pathologic scenarios. The proposed systems build off of our Preliminary Data where we have demonstrated bioreactor and system designs to generate functional platelets in vitro (Lovett et al., 2007; Pallotta et al., 2011). The goal is now to build on this success to optimize functional platelet formation (Aim 1), to compare platelet formation from normal vs. disease megakaryocytes (Mks) in the bioreactor (Aim 2) and to gain a fundamental basis for differences. The two major outcomes will be (a) a production system for functional platelet formation, and (b) mechanistic insight into normal vs. disease states related to Mk development for platelet formation. The hypothesis is that engineered microenvironments in vitro can be tailored to optimize the formation of functional platelets. Specific Aim 1 - Establish a bioreactor system to form functional platelets - Our hypothesis for this Aim is that an in vitro tissue/bioreactor system that mimics the bone marrow environment can provide improved understanding of megakaryopoiesis for functional platelet formation. In Aim 1.1 we will build upon our recently established bioreactor system (Lovett et al., 2007; Pallotta et al., 2011) and refine this system to optimize Mk functions towards platelet formation. Specifically: (a) collagen gel content - concentration and matrix proteins (von Willebrand factor (vWF), fibrinogen (FBG) or type I, IV collagens), (b) vascular conduits from silk protein - coatings with matrices (vWF, FBG or type IV collagens) to promote cell migration to the vascular niche, (c) surface hydrophilicity of the vascular tubes - modification of the silk tube wall, to foster Mk adhesion and maturation, (d) vascular tube porosity to optimize platelet shedding into the vascular flow, (e) vascular wall thickness to support cell maturation without efflux of the cells into the vascular flow, and (f) medium flow rate in the bioreactor to optimize cell migration and platelet formation. In Aim 1.2, we will investigate the mechanisms that lead to functional platelets, a major advance for the field (Reems et al., 2010). To address this Aim we will compare alpha granule distribution and content by thin-section transmission electron microscopy (TEM) and by immunogold electron microscopy. Further, we will analyze the impact of different shear rates in platelet production (Dunois-Larde' et al., 2009; Mazzucato et al., 2009) by analyzing platelet activation and thrombus formation (Mazzucato et al., 2009). In Aim 1.3, we will combine the insights from Aims 1.1 and 1.2 to modify our current bioreactor to increase the yield of functional platelets. The outcomes from Aim 1 will be insights into mechanisms driving functional platelet formation and optimization of platelet yields from the bioreactor. Particular attention will be addressed to Mk migration within the bioreactor related to Mk adhesion and maturation, as these are key issues for platelet formation, production and collection. Further, we will focus on the function of released platelets via platelet activation and thrombus formation. Specific Aim 2 - Mechanistic insight of normal vs. pathological megakaryopoiesis - We will study Mks from patients with and without platelet-related diseases, such as MYH9-RD (Myosin9 related disease) for platelet formation in the bioreactor system. Mk migration, proplatelet formation and platelet release in terms of morphology, yield and function will be investigated. This system will allow us to probe differences related to disease state by comparing outcomes between normal vs. disease cell sources. In particular we will analyze the regulatory mechanisms involved in megakaryopoiesis within the vascular and osteoblastic niches established in the bioreactor, with a focus on how these variables impact cell maturation, migration and platelet formation in disease cells. Specific areas of focus for mechanistic insight will include pathways underlying integrins and receptors on Mk membranes: integrins alpha2beta1, GPVI, GPIb-V-IX. Moreover, to assess the role of oxygen and nutrients in our 3D system we plan to investigate apoptosis-like activity of collected platelets and to compare this with in vitro 2D released platelets and human blood platelets. The outcome from this Aim will be insight into mechanisms of platelet production in healthy vs disease states related to platelet functions.